Regulation of the cell cycle by SCF and APC/C ubiquitin ligases

R01-GM57587, which supports our mechanistic studies of SCF and APC/C ubiquitin ligases, was severely compromised by the hurricane Sandy. This application represents a request of a twelve months cost extension to allow us to recover the time lost and re-generate valuable lost reagents that were generated during the first two years after this grant was competitively renewed. These “home-made” reagents are absolutely required to perform the projects covered by R01-GM57587.

Public health relevance
Cells depend on the proper functioning of an ensemble of networked, molecular machines to control diverse processes, ranging from cell proliferation to cell death to differentiation. The ubiquitin system can rapidly degrade the modular regulatory components of these machines, contributing to the precise operation and synchronization of complex cellular processes. Given its critical role, the ubiquitin system is often deregulated in cancer cells. Thus, it is anticipated that the results of the proposed studies will have an impact on both basic science and cancer biology.